Spatial Resynchronization Therapy for AFib

ABSTRACT
More than 450,000 hospitalizations each year in the US are due to atrial fibrillation (AF) which contributes to
approximately 160,000 deaths. The incidence of stroke, morbidity, hospitalization and mortality is further
exacerbated by the 40% of heart failure (HF) patients who suffer from AF. The intertwined pathology between
AF and HF have emerged as global epidemics poised to dominate cardiovascular care for the next half-century,
imposing a staggering $372 million annual increase to the US healthcare system, and amplifying the urgency for
effective therapies. Catheter ablation has become an increasingly common treatment for AF despite limited and
highly variable success rates and complications, with arrhythmia-free survival rates < 29% at 5 years. The current
acute standard of care is external cardioversion, with or without antiarrhythmic drugs. Unfortunately, high-voltage
external shocks are extremely painful, can cause additional arrhythmias, and often require escalation of care at
an annual cost of ~$26 billion. Efforts to address this unmet need have focused on internal atrial cardioversion,
which has not been widely adopted due to the invasiveness and patient intolerability of the pain from high-energy
shocks. The Maxwell Biomedical Spatial Resynchronization Therapy (SRT) System resolves the limitations of
high energy cardioversion for treating AF by utilizing spatiotemporal identification of the excitable gap and ultra-
low energy stimulation within the gap to globally advance refractoriness of complex reentry patterns enabling
imperceptible pace-termination of AF. This is accomplished via a multi-site pacing electrode array lead system
(MPEALS), which consists of multiple paired electrodes that, when implanted, are distributed across the
posterior-inferior epicardial region of the left atrium and tunneled to a subcutaneous pocket located under the
left arm/shoulder and connected to a rechargeable pulse generator. The system records cardiac electrograms
from each of the electrodes and the algorithm analyzes these signals to determine electronic selection and timing
of stimulation at each electrode using a state-of-the-art method from Dynamical System Theory. Importantly, it
operates below 0.1 J, an order of magnitude below the threshold for pain. Evidence for the effectiveness of this
approach has been shown in bench simulations, in vivo swine, and first-in-human studies (n=10) where an
external system (MAX-SRS) connected to commercially available multipolar catheters placed during open-heart
surgery achieved 83.3% global synchrony across 48 independent test runs, demonstrating a remarkable ability
to effectively terminate AF. The Maxwell Biomedical SRT system is now ready for final refinement of the algorithm
(Aim 1) in parallel with development of the MPEALS (Aim 2) which will be evaluated for efficacy, safety and
deliverability with an implantable pulse generator as a complete system to capture, gain control and terminate
AF in an in vivo animal model of AF (Aim 3). Successful execution of Phase II studies will position the SRT
system for IDE approval to conduct the clinical studies required for PMA approval of a highly disruptive
technology to treat the growing population of patients with AF and HF.

Public health relevance
NARRATIVE Current technologies and techniques are unable to reliably reduce AF event rates in a growing number of patients. The objective of this proposal is to validate the efficacy and initiate formal development of a novel multi- site pacing system that recognizes, and imperceptibly pace terminates AF.